Nicotine and Tobacco Misinformation on Youth-Oriented Social Media Platforms

ABSTRACT
Use of nicotine and tobacco products (NTPs) among youth is a persistent public health problem in the United
States. Initiation of NTPs in adolescence is associated with increased frequency of use, adverse impacts on
brain development, nicotine addiction, and increased risk of cancer. Major factors associated with NTP use
include youth-targeted marketing and media advertisements for these products; this is particularly true for
Black, Hispanic, and sexual and gender minority (SGM) youth. These youth are intentionally targeted with
messaging by nicotine and tobacco companies through carefully curated media advertisements and marketing
meant to build trust and recruit new users. With the proliferation of social media, this is more pervasive as
these youth are now exposed to messaging from both tobacco company marketing and self-generated content
from social media users. However, it is not well known how these youth are exposed to NTP-related
misinformation on social media and how these exposures are associated with susceptibility to NTP initiation.
Therefore, the goal of this proposal is to first identify NTP-related misinformation on a variety of youth-oriented
social media platforms and then assess associations between misinformation exposure and susceptibility to
NTP initiation among youth, particularly youth who identify as Black, Hispanic, and/or SGM. Informed by these
results, we will develop health communication messages to counteract misinformation and assess their
acceptability to youth. Core to this proposal is the use of a Youth Participatory Action Research approach via
the development of a Youth Collaborative (n=20). Comprised of an inclusive group of youth ages 13-17, the
Youth Collaborative will play an integral role in completing the following specific aims: (1) classify the most
pervasive and salient NTP-related misinformation on youth-oriented social media platforms via human-
centered design (HCD) activities, social media data collection, qualitative and automated data analysis
processes, and social network analysis; (2) assess social media-based exposure to NTP-related
misinformation and associations with susceptibility via a cross-sectional survey of with 700 youth ages 13-17
with oversampling of Black, Hispanic, and SGM youth; and (3) develop health communication messages using
HCD activities and assess the acceptability of these messages with a subsample of youth from Aim 2 who are
susceptible to NTP initiation. Our interdisciplinary team has collaborated for over a decade to examine youth
attitudes and behaviors related to nicotine and tobacco products, social media use, engagement with media,
and community-based participatory research. We will leverage this knowledge and experience to complete
these aims, the results of which can be used to develop scalable interventions that can counteract targeted
misinformation and prevent NTP initiation among Black, Hispanic, and SGM youth and ultimately eliminate
disparities in tobacco-related morbidity and mortality, including cancer, among these populations.

Public health relevance
NARRATIVE This proposal will use young people as scientific partners to identify nicotine and tobacco- related misinformation on social media. In collaboration with these youth, we will then assess how interacting with this type of misinformation is associated with susceptibility—or being willing to try a nicotine or tobacco product—among youth ages 13-17, particularly Black, Hispanic, and sexual and gender minority (SGM) youth. This information will be used to develop messages to counteract misinformation, and we will assess how acceptable the messages are to young people through surveys and interviews.